Lipid metabolism in the growth plate

PROJECT SUMMARY
Longitudinal bone growth takes place in the growth plate (GP), where chondrocytes proliferate, synthesize
extracellular matrix, and differentiate into hypertrophic chondrocytes. During puberty, the energy requirements
of chondrocytes are increased due to their rapid proliferation and extensive matrix production, and inadequate
energy supply as in malnutrition causes growth failure. Due to its avascular and hypoxic environment, it has
been thought that the GP uses little lipids for fuel because lipid metabolism, such as fatty acid oxidation (FAO),
requires oxygen. Instead, anaerobic glycolysis is thought to be the primary source of energy. On the other
hand, diseases that affect lipid metabolism such as peroxisomal disorders and lipid storage disorders also
cause short stature, raising the possibility that lipids may play an important role in the GP. However, lipid
metabolism in the GP is poorly understood. Although the GP is avascular, it is flanked by two bone marrow
cavities, and the upper and lower zones which are the resting and hypertrophic zones, respectively, are
adjacent to blood vessels, suggesting that these zones have access to oxygen and nutrients in the circulating
blood. Indeed, our preliminary studies have shown that the resting zone contains many lipid droplets (LDs).
When fluorescently labeled lipids were injected intravenously, these lipids were observed in the resting zone
within a few hours but disappeared within 24 hours, suggesting that chondrocytes in the resting zone actively
capture and consume lipids from circulation. Consistently, lipidomic analysis of cultured primary chondrocytes
detected Acyl-Carnitines, FA derivatives generated for FAO. Together with the recent finding that inhibition of
mitochondrial oxidation in GP chondrocytes resulted in short limbs, these results suggest that GP
chondrocytes are capable of utilizing lipids for energy production via FAO. In addition, we found that these
chondrocytes containing LDs in the resting zone exclusively expressed Apolipoprotein E (ApoE), a lipid
transporter. ApoE conditional knockout (KO) mice in chondrocytes had significantly shorter limbs. Lipidomic
analysis of ApoE KO chondrocytes revealed altered lipid profiles compared to WT chondrocytes. These results
suggest that ApoE endogenously expressed in chondrocytes plays an important role in bone growth and lipid
metabolism. Therefore, we hypothesize that GP chondrocytes utilize lipids as an energy source and intrinsic
ApoE in the resting chondrocytes mediates the initial lipid metabolism. This hypothesis will be addressed with
the following Aims: (1) to determine whether the growth plate utilizes lipids as an energy source, (2) to identify
the role of endogenous ApoE in the growth plate. Completion of these Aims will determine whether GP
chondrocytes utilize FAO in vivo and whether this has biological significance. The outcome will revolutionize
our understanding of energy metabolism in the GP.

Public health relevance
PROJECT NARRATIVE Diseases that affect lipid metabolism cause growth inhibition; however, the mechanism remains unknown due to the lack of knowledge about lipid metabolism in the growth plate. In this proposal, we will use unique transgenic mouse models that can inhibit the use of lipids in the growth plate to comprehensively determine whether the growth plate uses lipids for energy production. The outcome of this proposal will advance our understanding of growth plate metabolism, which will lead to the elucidation of mechanisms underlying growth failure in lipid metabolism disorders.